CHAIRS-C: Climate, Health, and Aging Innovation and Research Solutions for Communities

The Community Engagement Core (CEC) of CHAIRS-C will promote multi-directional communication among
the Center and its investigators; older adults; community partners who provide services to older adults and who
are committed to climate justice; and policy makers. The CEC will establish and sustain meaningful and
productive engagement between Brown researchers and community partners, using the Spectrum of
Community Engagement to Ownership framework, which outlines a path to enhance and advance meaningful
engagement of relevant communities in the research process. The long-term objective of the Center is to
develop, deliver, and translate research into equitable solutions that promote healthy aging and protection from
the health impacts of climate change for all. To achieve this long-term objective, the CEC has identified the
following specific aims: 1) Facilitating engagement of community members and partners in multi-directional
communication on issues relating to climate change and healthy aging; 2) Translating and disseminating
findings from climate change and health research with those most likely to be impacted and to benefit,
including older adults, community partners, and government agencies; and 3) Evaluating our engagement,
translation, and capacity building efforts. Completion of these aims will develop, expand, and sustain
engagement of community partners, including experts in climate science, environmental health, and the
provision of services to older adults. This engagement will allow us to develop and deliver actionable and
equitable strategies to promote healthy aging in the face of climate change.